Investigating the role of Ets1 in natural killer cell terminal maturation and function

Project Summary
NK cells are fast-acting, cytotoxic immune cells vital for protecting against herpesviruses and cancer.
Given their ability to identify infected and transformed cells in an MHC class I-independent manner, NK cells
have become increasingly studied for their potential as off-the-shelf immunotherapies. While NK cells exhibit
tremendous potential for future technologies, many strategies have been hindered by our limited knowledge of
the factors that guide expansion, terminal maturation, and cytotoxicity. Here, we propose to study how Ets1, a
highly conserved and tightly regulated transcription factor in lymphocytes, contributes to mature NK (mNK) cell
terminal maturation and function.
To address the role of Ets1 in mNK cells, I generated an NK cell-driven Ets1 conditional knockout mouse
line (Ets1 cKO, Ncr1Cre Ets1F/F). These mice generate biallelic deletions of Ets1 in mNK cells without affecting
other lymphocyte lineages. Preliminary data presented here demonstrate that the loss of Ets1 in undifferentiated
mNK cells results in a severe population defect in the bone marrow and spleen with a specific loss of the
differentiated, cytotoxic effector subset. To address the role of Ets1 in cytotoxic effector competent mNK cells, I
generated a tamoxifen-inducible NK-cell driven knockout mouse line (Ets1 TAM-KO, Ncr1ERT2 Ets1F/F) that
efficiently deletes Ets1 in differentiated mNK cells without inducing a maturation block. Preliminary data from
these mice suggests that Ets1 is not required for differentiated mNK cell survival, but may limit terminal
maturation and cell activation.
The goal of this project is to establish the mechanistic role of Ets1 in mNK cells. We propose two aims
that will (i) establish how Ets1 promotes the development of undifferentiated mNK cells into the cytotoxic effector
subset and (ii) determine how Ets1 expression in differentiated, cytotoxic effector NK cells regulates terminal
maturation and function. Accomplishing the proposed studies will illuminate outstanding developmental and
functional questions and contribute to the exciting and growing field of NK cell biology. These studies will help
detail molecular mechanisms of Ets1 in mNK cells and may inform the design of improved NK cell-based
immunotherapies.
This project is accompanied by a training plan developed by my mentors and me that delineates several
goals needed to propel me toward becoming a successful independent physician-scientist. These goals include
gaining expertise in interrogating transcription factor functions in immune cells, refining my skills in
bioinformatics, developing proficiency in scientific communication, and integrating my scientific and clinical
training. Realizing these goals will equip me with fundamental skills that will support my aspirations to become
a physician-scientist oncologist capable of spearheading novel therapeutic avenues.

Public health relevance
Project Narrative Natural killer (NK) cells are uniquely poised to serve as the foundation for immunotherapies, given their ability to recognize and rapidly eliminate virus-infected and transformed cells. This proposal seeks to establish the molecular mechanism of Ets1, a highly conserved and tightly regulated transcription factor, in NK cell terminal maturation and function. The results from this study will contribute to a growing body of literature relating to NK cell expansion and cytotoxicity and may inform the design of improved NK cell-based technologies.